Loyola-Ukrainian Catholic University International Bioethics Research Training Program

Project Summary/Abstract
The Loyola University Chicago-Ukrainian Catholic University (LUC-UCU) Doctoral and Post-
Doctoral Bioethics Training Program will provide advanced doctoral-level education in research
ethics in English to Ukrainian scholars. The aim of this program is to educate a critical mass of
bioethics experts who will hold positions of leadership in health research institutions in Ukraine
and contribute to bioethics scholarship. During five years of funding, approximately 12-15
trainees (10-12 doctoral fellows and 2-3 postdoctoral fellows) will be selected for their
demonstrated commitment to advancing bioethics, ethical research, and research integrity in
Ukraine and their potential for success as independent scholars. Doctoral fellows will spend
approximately 3-4 years completing coursework in Loyola’s online doctoral bioethics program
while living in Ukraine. They will also participate in monthly webinars on academic success and
professional development; attend annual intensive in-person workshops; and contribute to
bioethics-related activities at UCU. They will be supported to publish their conceptual and
empirical scholarship in international peer-reviewed bioethics journals. Post-doctoral fellows,
who should ideally have faculty appointments at Ukrainian institutions of higher education, will
conduct mentored research projects as well as design and implement a bioethics-related
program at their home institution. All doctoral and post-doctoral fellows’ academic, research,
and professional development activities will be guided by an individual professional
development plan prepared jointly by the fellow, the program director, and the two mentors (one
at LUC and one in Ukraine). Upon completion of the program, fellows will have a strong
foundation in bioethics research design, methods, and analyses; have a solid understanding of
bioethics theory and ethical practice related to global health research; and be able to
independently conceptualize, analyze and solve bioethics research problems. Competencies
gained will allow fellows to hold leadership positions at their institutions and teach bioethics,
lead ethical review of research, and provide consultation on ethical issues to biomedical and
behavioral and social science researchers. As research activity increases in Ukraine, these
individuals will be instrumental in providing direction on matters of research ethics not only to
their own institutions but to government agencies and international organizations.

Public health relevance
Project Narrative This fellowship program, a partnership between Loyola University Chicago and Ukrainian Catholic University, aims to provide doctoral and post-doctoral bioethics education to Ukrainian scholars who will conduct conceptual and empirical research on research ethics as well as educate and consult with researchers and research ethics committee members across Ukraine. The development of research ethics scholars is critical to the protection of human research participants and public trust in global research.